Optimizing Nanopore Protein Interactions

? DESCRIPTION (provided by applicant): Electronic BioSciences (EBS) will begin examining the characteristics and interactions that will eventually enable nanopore based differentiation of peptides and amino acids. Although there are numerous components of a complete nanopore based protein characterization system that will ultimately need to be developed, during the course of this two year program EBS will focus solely on the detection and differentiation methodologies in order to demonstrate basic feasibility and proof-of-concept. The information generated from these studies will provide the foundation for developing the nanopore based protein characterization concept and eventually will lead to the development of cutting edge proteomics instrumentation.

Public health relevance
PUBLIC HEALTH RELEVANCE: This program is aimed at developing and validating the individual components that may one day lead to an entirely new method of characterizing proteins. Rapid, reliable, high throughput, and low cost protein sequencing and characterization will enable a more comprehensive assessment of gene expression, protein variations and post translational modifications, along with faster disease biomarker discovery and validation, and enhanced clinical testing and monitoring of diseases.